PURINE/PYRIMIDINE THERAPY IN A DISORDER OF NUCLEOTIDE METABOLISM

To determine whether increased pyramidine and possibly purine nucleotide catabolism is responsible for symptoms of speech and developmental delay, intermittent ataxia, strabismus, recurrent seizures and immune dysfunction.